Post-transcriptional modification in esophageal basal cells.

SUMMARY
Balanced self-renewal and differentiation of basal cells is critical for the homeostasis and regeneration of the
esophageal epithelium. Microenvironmental challenges including injury and allergy alter basal cell capability,
leading to pathologies such as basal cell hyperplasia which is a key feature of eosinophilic esophagitis (EoE).
We and others previously show that signaling pathways (e.g. BMPs) regulate the transcription of downstream
targets to influence basal cells through transcription factors like p63. In contrast, little is known about how
modifications of the resulting transcripts modulate basal cells. In this proposal we will fill the knowledge gap and
provide initial insights into the mechanism by which posttranscriptional regulations modulate basal cell activities
during homeosis and injury/repair. We will also investigate the role of posttranscriptional regulations in EoE basal
cell hyperplasia. Specifically, we will study how Mettl3/14 complex-mediated RNA modifications are involved in
these processes. Our central hypothesis is that Mettl3/14-mediated m⁶A deposition on transcripts
including p63 is critical for maintaining basal cells and tissue integrity. We will test the hypothesis
with three specific aims. Aim 1 will identify and determine the function of Mettl3/14-modified transcripts in basal
cells. We will use a combination of mouse genetics, Nanopore sequencing, proteomics and CRSPR/Cas9 to
identify and functionally test mRNA substrates that are modified by the Mettl3/14 complex. We will also study
whether p63 transcripts are modified by the methylation complex. Aim 2 will determine the role of Mettl3/14 and
p63 in basal cell-driven regeneration. We will use Mettl3 gain- and loss-of-function mouse models combined with
p63 mutants to study how RNA modifications affect injury/repair of the esophagus. Aim 3 will test the hypothesis
that inhibition of Mettl3/14 and p63 attenuates basal cell hyperplasia in an EoE mouse model. Together these
studies will help us gain a better understanding of the normal mechanism regulating basal cell activities,
meanwhile identifying new potential therapies for treating EoE.

Public health relevance
Narrative Despite significant advances in understanding the role of transcriptional regulation in esophageal homeostasis and regeneration, the involvement of posttranscriptional regulation in these processes remains largely unexplored. Our proposed study aims to uncover how RNA modifications mediated by the Mettl3/14 complex regulate basal cell activity during regeneration and eosinophilic esophagitis. The insights gained from this research will establish a foundation for enhancing recovery after injury and identifying novel therapeutic approaches for treating eosinophilic esophagitis.